Amphetamine in adolescence disrupts frontal cortex development

Adolescence is an age of increased vulnerability to psychopathology, including drug abuse. My work concerns
the molecular events underlying the maturation of the medial prefrontal cortex (mPFC) in adolescence and the
effect of stimulant drugs on these processes. My ultimate goal is to unravel the molecular factors mediating risk
and resilience in adolescence to the deleterious effects of drugs of abuse in males and females. Our work has
focused on the impact of amphetamine (AMPH) on the development of the dopamine (DA) innervation to the
mPFC. We discovered that DA axons are still growing toward the mPFC across adolescence, remaining
particularly susceptible to disruption. This delayed DA axon growth is controlled by the guidance cue receptor
DCC, which determines whether, when, and where DA axons stop or continue to grow. Notably, AMPH in early
adolescence dysregulates DCC expression and also induces profound changes in mPFC DA synaptic
connectivity/function and causes deficits in cognitive control in adulthood. Until very recently all our studies
have been focused on male mice only. In addition, we have been investigating only AMPH effects of doses that
reach plasma levels equivalent to those seen in recreational drug users. Our recent preliminary data suggest,
however, that the vulnerability to the effects of AMPH on mPFC DA development is sex-specific. Also, recently
published results show that therapeutic-like doses during this time induce opposite, even beneficial enduring
effects. The experiments now proposed are designed to test the following working hypotheses: (a) that the
vulnerability to AMPH-induced disruption of mPFC development at particular adolescent time windows is
sexually biased, (b) that this dimorphism also impacts detrimental drug effects on adult cognitive processing,
(c) that sex-specific control over DCC receptor expression in DA neurons mediates differential drug
vulnerability/resilience (d) that these effects are dependent upon recreational- versus therapeutic-like
exposure. Methods: To address these questions, we will conduct molecular, anatomical, neurochemical, and
behavioral experiments in male and female mice. Our studies will combine dual viral transduction strategies
and quantitative neuroanatomical analyses to track DA axon targeting and growth in adolescence. To measure
DA function, we will use novel and temporal-sensitive measurements of in vivo DA signaling (dLIght1) in freely
moving mice. To identify mechanisms underlying the dimorphic vulnerability to AMPH, we will perform gain-
and loss-of-function experiments using neuron optimized CRISPR and Cre-Lox recombination strategies.

Public health relevance
My research concerns the question of why drug use in adolescence is a strong predictor of lifetime abuse. To answer this, I study the effects of stimulant drugs on the molecular and structural changes that are ongoing in the brain during adolescence. This work is carried out in both males and females investigating the effects of therapeutic-like doses and excessive drug exposure.